Climate Variability and Respiratory Health in Asthma and COPD

Dr. Nicholas Nassikas is a pulmonary and critical care physician whose long-term career goal is to determine
how climate-related exposures affect the respiratory health of people with chronic lung disease and to devise
strategies to prevent or mitigate such effects in the context of climate change. He has assembled a
multidisciplinary and multi-institutional mentorship team with expertise in environmental epidemiology (Drs.
Rice and Gold) and asthma disparities (Dr. Israel), who have demonstrated a firm commitment to his long-term
success as a clinical investigator. As part of the award, Dr. Nassikas will extend his skills in biostatistics,
epidemiology, and statistical programming through formal coursework to obtain a Master of Public Health.
Rates of global warming are doubling every decade, causing heavier precipitation and warmer, more variable
temperatures across the United States, with significant implications for human health. Dr. Nassikas’ study will
evaluate associations of temperature and precipitation, and the extremes of each, on the respiratory health of
those with chronic obstructive lung disease and in vulnerable populations, including Black/Latinx communities
who may be differentially exposed. His central hypothesis is that higher levels and variability of temperature
and precipitation will be associated with more respiratory symptoms and exacerbations, lower lung function,
and higher airway inflammation in adults with asthma and COPD. Dr. Nassikas will leverage three existing
well-characterized cohorts and recruit a prospective cohort of adults with asthma. He is well positioned to test
his hypotheses in the following aims: (1) Determine if monthly extreme weather events (high/extreme heat, high
wet-bulb globe temperature, heavy precipitation), temperature, and temperature variability are associated with
respiratory symptoms and events in adults with chronic obstructive lung disease, (2) Determine if short-term
differences in weather conditions are associated with lung function and airway inflammation in adults with
chronic obstructive lung disease, and (3) Determine if temperature, temperature variability, and precipitation
are associated with differences in symptoms and lung function in adults with asthma and, secondarily, to
evaluate if associations are mediated by exposure to mold and aeroallergens. There is a very strong working
history between the members of Dr. Nassikas’ mentorship team (Drs. Rice, Gold and Israel), who have
published over 27 peer-reviewed manuscripts together. The well-coordinated supervision of Dr. Nassikas’
research activities and career development by his mentorship team follows an existing successful mentorship
model. He will benefit from the outstanding and complementary environments at Beth Israel Deaconess
Medical Center, Harvard School of Public Health, Brigham and Women’s Hospital, and the Harvard-NIEHS
Center. This proposal will provide valuable data and training in epidemiology and prospective study design and
execution, which will lead directly to future R01 applications and support his development as an independent,
grant-funded investigator.

Public health relevance
PROJECT NARRATIVE In order to protect public health from a rapidly changing climate through preventive patient care and public health policies, it is essential for the medical community to understand the impact of temperature, precipitation, and its extremes on respiratory health, particularly in those disproportionately impacted by climate change, such as individuals with asthma and COPD, and Black and Latinx communities. The results of this study will provide valuable data to understand relationships of temperature and precipitation with asthma and COPD. This data will support future investigation of interventions, such as air purification and community cooling centers, to build resiliency and adaptation to a rapidly warming world.